Cognitive aging in long-term breast cancer survivors

ABSTRACT
Despite significant progress in understanding cognitive change associated with cancer and cancer treatments,
little is known regarding longer-term cognitive outcomes over developmentally meaningful intervals in older age
(5-20 years post-treatment) and potential association with frailty. Previous work from our lab and others, focusing
on the direct effects of cancer and cancer treatment, has moved the field forward for a better understanding of
these direct effects but is limited with regard to tracking long-term cognitive trajectories due to 1) focus on
cognition before and after treatment and short intervals following treatment completion; 2) longitudinal designs
that introduce practice effects and selective attrition that distort true cognitive trajectories; and 3) short intervals
that also limit the ability to assess accumulation of deficits, i.e., frailty, to potentially associate with cognitive
declines. We will assess cognition in 210 cancer survivors diagnosed between 55 and 60 years of age and 210
non-cancer controls at three cross-sectional age bands: 65-69; 70-74; 75-80. Cognitive assessment will consist
of online, remote administration of a validated platform of cognitive-experimental measures for use in cancer
survivorship and standard neuropsychological measures, together with collection of cancer and treatment
variables. Frailty as indexed by accumulation of deficits, i.e., medical comorbidities, polypharmacy, social
detriments of disease (e.g., smoking, obesity), psychological disturbance, and functional limitations / declines in
activities of daily living, will be collected in parallel. Aim 1: Examine cognitive differences and trajectories
between breast cancer survivors and age and education matched controls controlling for cognitive
reserve and APOE. Aim 2: Examine the association of deficit accumulation with cognition and
interaction with group status. Aim 3: Explore potential associations between APOE status and deficit
accumulation and combined effects on cognition. This research is significant because cancer and cancer
treatments have been identified as disease drivers of aging and deficit accumulation and has significant clinical
implications in that interventions that reduce deficit accumulation may be effective in maintaining cognitive
function. This research is innovative because it utilizes a cross-sectional design that avoids practice effects and
cognitive neuroscience measures that allow for assessment of cognitive trajectories and their association with
deficit accumulation at developmentally relevant timespans.

Public health relevance
PROJECT NARRATIVE Despite significant progress in understanding cognitive change around the time of breast cancer diagnosis and treatment, little is known regarding long-term cognitive trajectories and how these might be impacted by a history of cancer and cancer treatment. The overall goal of this proposal is to collect and analyze cognitive performance data at developmentally meaningful intervals 5-20 years post-treatment in older cancer survivors to determine whether cognitive performance remains stable or instead increasingly declines compared to individuals without a cancer history. We will also examine cognitive trajectories for their association with differential deficit accumulation in survivors compared to controls. This research is significant and innovative because little is known about potentially altered cognitive trajectories and the design and methods proposed will be able to characterize these trajectories and potential association with deficit accumulation.